Regulation of Gastrointestinal Eosinophils

Project Summary/Abstract
The long-term goal of this study is to determine the regulation and function of gastrointestinal (GI) eosinophils,
a cell associated with multiple inflammatory diseases, especially a new set of emerging chronic allergic diseases
referred to as eosinophilic GI diseases (EGID). Whether GI eosinophils exist as heterogeneous cells and
subpopulations is currently not known. This is an important subject as distinct cell populations may have different
roles in disease and during homeostasis. Understanding this subject has significant clinical implications in view
of the emerging class of new drugs that target eosinophils. Perhaps only a specific population of eosinophils
should be ablated and only in certain patients. The central hypothesis is that GI eosinophils are dynamic,
transcriptionally active cells regulated epigenetically by local microenvironmental cues and that these processes
lead to heterogeneous cell populations, under homeostatic and disease conditions. The rationale for this
hypothesis is based on the findings that eosinophils express dynamic transcriptomes characterized by distal
regulatory elements associated with histone 3 lysine 27 acetylation (H3K27ac) and binding sites for the
transcription factor PU.1. We will test this hypothesis using recently developed innovations (e.g., ChIP-seq,
ATAC-seq, transcriptomics, ex vivo co-culture) that we have applied to study murine and human eosinophils. In
Aim 1, we will examine the epigenetic landscape and function of eosinophils. We will test the hypothesis that
eosinophils express dynamic transcriptomes and epigenomes under basal and IL-33–activated conditions. We
will mechanistically uncover the involvement of PU.1 as a prototypic transcription factor that regulates eosinophil
enhancer function. We will elucidate the epigenetic and transcriptional mechanisms underlying eosinophil
responses to a microenvironmental stimulus, IL-33. In Aim 2, we will examine GI eosinophil heterogeneity, aiming
to test the hypothesis that murine GI eosinophils exist as heterogeneous populations defined by their epigenomic
and transcriptomic landscapes and their proteomic content and functional capacity. In Aim 3, we will examine
eosinophil heterogeneity in EGID. We will compare the epigenome, transcriptome, and proteome of human blood
and GI tissue eosinophils in healthy and diseased individuals. We will model the interplay of eosinophils with key
microenvironmental factors that are likely to influence these processes (e.g., co-culture with epithelial cells and
relevant activating cytokines [IL-13]). We are hopeful that the renewal of this grant will allow the elucidation of
the fundamental properties of GI eosinophils to continue. We anticipate that the findings from this grant will lay
the foundation for defining eosinophil subpopulations in mice and humans. The importance of this undertaking
(identifying subtypes and functions of eosinophils unique to different tissues) was highlighted in a recent NIH
Taskforce on the Research of Eosinophil-Associated Diseases (RE-TREAD), emphasizing the potential
significance of this proposal. In addition, the findings generated have the potential to advance the understanding
of EGID and a variety of aspects of mucosal immunology.

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding gastrointestinal eosinophils and their heterogeneity and subtypes is expected to contribute to better diagnostics and treatments of a variety of gastrointestinal eosinophilic diseases. Thus, this proposal is relevant to the part of NIH's mission that pertains to fostering fundamental creative discoveries and innovative research strategies as a basis for ultimately protecting health.